Neurogenomics of Vulnerability and Resilience to Mental Health Syndromes in Response to Extreme Life Events

Acute stress and chronic adversity affect biological systems at multiple levels, contributing to diverse mental and
physical health outcomes. Yet, the mechanisms through which these stressors impact health—and the factors
that foster resilience or increase vulnerability—are not well understood. The free-ranging rhesus macaques
(Macaca mulatta) on Cayo Santiago island offer a unique natural experiment. In 2017, they experienced a
Category 4 hurricane, followed by acute deprivation of food and water (later restored) and chronic deforestation,
which led to sustained higher temperatures. Building on our prior R01- MH118203 support, we will use this
setting to investigate how environmental stressors affect the brain. Our previous work established a
comprehensive biobank from macaques with varied social status and connections, sampled before and after the
hurricane. We found that social support protects against both chronic adversity (e.g., low social status) and acute
trauma (e.g., natural disasters), with strong links to health, aging, and survival. With renewed support, we aim to
expand these findings by examining molecular and anatomical variations in brain pathways associated with
social connectedness, adversity, and stress. First, we will quantify the hurricane's short-term effects on brain
health by comparing cohorts sampled before and shortly after the event. Using MRI and molecular data, we will
assess the impact of social environment and hurricane exposure on brain phenotypes, identify regions vulnerable
to hurricane stress, and examine whether hurricane-exposed animals show adverse molecular and
neuroanatomical changes. We hypothesize that animals with higher social capital–the combination of social
connections and social status–will demonstrate greater resilience, with social capital modulating molecular
mechanisms that shape neural circuits. Next, we will analyze animals sampled in the following years to explore
how social environment and hurricane exposure, combined with long-term environmental changes, influence
brain health. Finally, we will prospectively sample animals exposed only to the altered post-hurricane
environment to distinguish the effects of surviving a disaster from those of living in a chronically degraded
environment. This project will precisely map the structural and molecular pathways by which social capital fosters
resilience, a depth unachievable in pre-mortem human studies across lifespan-relevant timescales. The
behavioral and biological similarities between macaques and humans endow this study with strong translational
potential for addressing anxiety, depression, and related health impacts—crucial priorities for NIMH (NOT-MH-
18-058).

Public health relevance
Precisely how chronic adversity and acute stress “get under the skin” to impact mental and physical health, and the biological and behavioral traits that foster resilience or vulnerability, remain poorly understood. In the prior support period, we demonstrated that social connections serve as a powerful neuroprotective factor against both chronic adversity (e.g., low status) and acute trauma (e.g., natural disasters) by developing a unique, comprehensive biobank of tissues from free-ranging macaques of varied social status and connections, sampled before and after a Category 4 hurricane, along with ongoing biological and behavioral data. With renewed support, we will expand these discoveries by deeply characterizing neuromolecular and neuroanatomical variation in brain pathways linking social connectedness, adversity, and stress, ultimately mapping biological pathways that translate social support into resilience, health, and survival with a precision unachievable in pre- mortem humans across lifespan-relevant timescales.